Healthy Immigrant Community: Mobilizing the Power of Social Networks

PROJECT SUMMARY/ABSTRACT - Project 1
Across many measures, immigrant populations arrive to the US healthier than the general population, but the
longer they reside in the US, the more their cardiovascular risk rises, mediated in part by systemic factors that
promote the adoption of unhealthy behaviors. Given the complex sociocultural forces that influence these
behaviors, a community-based participatory research (CBPR) approach is needed to address them. Rochester
Healthy Community Partnership (RHCP) is a CBPR partnership experienced at collectively deploying
interventions with immigrant groups. RHCP tested an intervention of 12 face-to-face modules to promote healthy
behaviors within immigrant populations. At 12 months, there were significant improvements in the primary
outcome of dietary quality compared with controls, suggesting this program could meet the unique needs of
immigrant communities. However, the intervention intensity limits its dissemination potential, and the intervention
did not explicitly address healthful weight loss, nor target overweight or obese participants. Subsequently, a
social network (SN) analysis of 1,301 Hispanic and Somali adults found that obesity and behaviors clustered by
ascertainable SNs. RHCP partners then re-designed existing intervention materials for overweight and obese
adults from immigrant communities to be delivered by peer interventionists within their social networks. The
resultant social network intervention was pilot tested with 4 groups (2 Somali, 2 Hispanic; total N=39); participants
demonstrated significant reduction in weight, blood pressure, and cholesterol as well as improvements in their
dietary quality and physical activity at 3 months (100% retention rate). Building on this, our overall objective is to
foster sustainable health promotion for Southeast Minnesota immigrant communities. The aims of this program
are to 1) assess the efficacy of a social network-informed CBPR-derived health promotion intervention on obesity
and other measures of cardiovascular risk in two immigrant communities; and, 2) assess the impact on
sustainability and uptake outcomes of embedding the intervention within a regional health promotion resource
hub. Using a stepped wedge cluster randomized design, 46 social network sub-groups of adults (23 Hispanic, 23
Somali) with approximately 322 participants (7 per group) will be randomly assigned to receive the intervention
either immediately or after a delay of one year. The intervention will consist of 12 community-based mentoring
and education sessions, followed by 12 maintenance sessions delivered by trained Somali and Hispanic
interventionists to members of their groups in a face-to-face or virtual format. Outcomes measured through 24
months, will be derived from the American Heart Association’s “Life’s Simple 7”: BMI and waist circumference,
blood pressure, fasting blood glucose, total cholesterol, physical activity level, and dietary quality. This program
will mobilize the power of SNs for scalable and sustainable solutions to obesity-related behaviors among difficult
to reach populations. CBPR enhances the relevance of this program by targeting sociocultural determinants of
these behaviors.